Kinetochore Interaction with Centromere Chromatin in human cells

Our goal is to dissect the mechanism by which kinetochore proteins binds the centromeric chromatin in the genome and creates the basis for a functional centromere. Since the project started by new postdoctoral associate in 2010, this work is in progress. A separate study was conducted in collaboration with a human pluripotent cell (hPSC) investigator Amander Clark (UCLA), where we discovered that the centromeric protein reserve plays a role in cell differentiation and in chromosome damage sensing. This work was published in Human Mol. Genetics August 2010. The follow up project was suspended due to the recent ruling on the use of hPSC in federally funded projects.